STRIDES Reporting Support - R Code Expanded Usage and Transition Activities

Refinements to the Tableau executive dashboard to integrate Azure data for intramural and extramural programs; to support current "edge case" cost reporting needs for popular cloud-based research platforms like Seven Bridges and Terra; and to provide additional data visualizations and dashboard functionality.